Sex-dependent Impairment of Nitric Oxide Signaling and Mitochondrial Metabolism in Radiation-Induced Cardio-Pulmonary Dysfunction

Whether accidental or intentional, ionizing radiation (IR) exposure poses significant risks to thoracic organs,
particularly the heart and lungs. It can lead to inflammation, fibrosis, and cellular senescence, resulting in a
range of clinical complications. These include pericarditis, coronary artery disease, valvular issues, heart
failure, arrhythmias, radiation pneumonitis, pulmonary fibrosis, and even mortality. Notably, there are sex-
based differences in how individuals respond to IR, with women often displaying greater susceptibility to long-
term IR toxicities. The exact mechanisms behind these sex-based disparities are still unclear, but they may
involve factors such as hormones, genetics, and metabolism. Nitric oxide synthase 1 plays a crucial role in
catalyzing nitric oxide biosynthesis. Preliminary research in mice exposed to 20 Gy cardiac-targeted IR showed
that they developed heart and lung abnormalities, including diastolic dysfunction, conduction issues, cardiac
fibrosis, and pulmonary congestion. However, male mice exhibited additional problems including left ventricular
dilation, systolic dysfunction, and alterations in mitochondrial electron transport chain complex II activity.
Interestingly, both male and female mice with decreased nitric oxide synthase 1 expression exposed to 20 Gy
experienced reduced left ventricular size and function, faster atrioventricular conduction, and no evidence of
diastolic dysfunction. Treatment with a superoxide dismutase mimetic, Rucosopasem, mitigated some of the
IR-induced cardiac changes in female mice. This data implies that sex-related differences in nitro-oxidative
pathways and disruptions in the mitochondrial electron transport chain metabolism could influence sensitivity to
cardio-thoracic IR. We hypothesize that IR-induced, sex-dependent alterations in redox signaling pathways
stemming from differences in mitochondrial electron transport chain activities between males and females lead
to changes in reactive oxygen species and reactive nitrogen species, which in turn mediate IR-induced cardiac
and pulmonary dysfunction. Aim 1 will use an upper body model of IR exposure to investigate the sex-based
effects of IR on mitochondrial oxidative metabolism in wildtype and heterozygous nitric oxide synthase 1
disrupted mice, its role in generating reactive oxygen and reactive nitrogen species, and its impact on cardio-
pulmonary function. Aim 2 will assess the effectiveness of Rucosopasem, a superoxide dismutase mimetic, in
mitigating IR-induced effects on the cardio-thoracic system in both male and female wildtype mice exposed to
upper body IR. Completing these studies could unveil sex-based disparities in redox metabolism and
mitochondrial dysfunction, potentially offering targets for preventing or reducing IR-induced cardio-pulmonary
toxicities. Rucosopasem might also emerge as a novel therapeutic approach for radiation mitigation.

Public health relevance
The origins of sex-based differences in ionizing radiation (IR) response remain unclear, potentially involving hormones, genetics, and metabolism. Preliminary mouse model studies hint at sex-specific shifts in nitro-oxidative pathways and mitochondrial superoxide dismutase activities as contributors to sex-specific IR-induced cardio-pulmonary toxicities. This proposal delves deeper into these mechanisms, providing insights into gender-specific factors and potential therapeutic approaches for mitigating IR-induced cardio-pulmonary toxicities.